Immune-derived mediators of salivary gland development and differentiation

Project Summary
Irreversible damage to salivary glands (SGs) and their diverse cell types, is a debilitating condition caused by
irradiation treatment for head and neck cancer, and the autoimmune disease Sjögrens Syndrome. Loss and
remodeling of SG epithelial cells results in hyposalivation, leading to significant clinical issues including chronic
dry mouth, increased dental caries, and oral infections. Currently, preventative and/or curative treatments do not
exist, yet cell-based bioengineering therapies hold significant promise for SG regeneration. A significant
hindrance to the progress of therapeutic optimization, however, is our incomplete understanding of the cellular
cues that regulate SG progenitor dynamics, differentiation and the establishment of a functional secretory organ.
The specialized branched architecture of the SG maximizes the total area of cell-cell contact between the
epithelium and the components of its microenvironment. This project aims to elucidate how immune cells of the
SG niche regulate coordinated epithelial cell processes. Our preliminary work using transgenic models defines
intimate interactions between tissue-resident macrophages and SG epithelial cells during critical timepoints of
SG formation, and preliminary cell depletion studies confirm the necessity of macrophages in guiding SG
establishment. Here, we will leverage our expertise in SG development, discrete progenitor dynamics and niche-
epithelial interactions to test the hypothesis that multiple aspects of SG morphogenesis are regulated by diverse
functionalities of tissue-resident macrophages. Using genetic mouse models and transcriptomic approaches, we
will determine how macrophages govern unique cell dynamics and the establishment of heterogenous SG cell
identities. We will further test the hypothesis that macrophage-derived signaling factors govern SG progenitor
cells and their directed cell expansion. Using biased cell-specific in vivo gene targeting and unbiased spatial
single cell transcriptomic techniques, we will determine common
immune-epithelial signaling networks, and
potential species-specific differences, required for SG epithelial patterning across human and mouse
development.
Outcomes from this study will identify novel immune-specific mediators of multiple SG epithelial cellular and
molecular processes and contribute at large to the advancement of therapeutic targets for salivary gland repair,
regeneration, and restoration.

Public health relevance
Project Narrative Hyposalivation, caused by irreversible damage to salivary glands, leads to significant clinical issues including chronic dry mouth, increased dental caries, and oral infections. This project aims to elucidate how tissue-resident immune cells regulate coordinated salivary gland epithelial processes by identifying the immune-derived signaling factors essential for progenitor dynamics and the establishment of a functional secretory organ. Outcomes from this study will identify novel immune-specific therapeutic targets for salivary gland repair, regeneration, and restoration.